Complementary ex vivo multimodal optical imaging and in vivo Raman spectroscopy to understand tissue dynamics

PROJECT SUMMARY
Limited approaches exist to examine longitudinal changes in the structural and biochemical properties of tissues
under various physiological conditions such as pregnancy. Light and light based technologies offer the potential
for non-invasive, real-time, in vivo monitoring of longitudinal shifts in tissue physiology in response to
developmental, hormonal, or environmental influences. The objective of the proposed research is to pursue a
multi-pronged platform with complementary Raman scattering approaches to study longitudinal changes in tissue
physiology in vivo as well as ex vivo and compare the results with conventional assays to validate our approach.
In addition, we will combine various forms of in vivo Raman imaging, including (i) dual wavelength, dual region
Raman (ii) polarization-sensitive Raman, and (iii) resonance Raman spectroscopy to quantitatively analyze
changes in tissue physiology. In response to a lack of detailed understanding of preterm birth and its tissue
biochemistry, our group has reported the utility of in vivo RS to detect and extract longitudinal biochemical
changes in the mouse as well as human cervix, a tissue that undergoes extensive remodeling over the course
of pregnancy. We established the ability of a conventional in vivo RS probe to identify significant spectral changes
in collagen, elastin, water, and blood. Moreover, we can correlate these Raman spectra with changes in
biomechanical properties of the mouse cervix, including stiffness and distensibility, as the cervical tissue
undergoes normal remodeling/maturation in preparation for labor. Building on our prior research, the present
proposal will focus multimodal ex vivo and in vivo Raman approaches to gain in-depth, quantitative information
during physiologic cervical maturation and in mouse models of premature remodeling. We hypothesize that
multimodal Raman approaches will enable detection of key biochemical changes, such as extracellular matrix
(ECM) organization, tissue hydration, lipid and protein influx and vascularity that will allow molecular and
structural phenotyping of the cervix as a prototype of physiologic tissue remodeling. Results will be correlated
with spatial information obtained via ex vivo imaging and biomechanical testing. Our Aims are to: 1) Implement
multimodal non-linear imaging to characterize changes in structural proteins in the mouse cervix, 2) Use dual
wavelength, dual region Raman Spectroscopy to track changes in tissue hydration and lipid dynamics, and 3)
Evaluate spatial and temporal changes in blood and vascularization in the mouse cervix over the course of
pregnancy. Ultimately, this project will integrate the results of these aims to provide a more complete picture of
the molecular and structural changes that can be used to understand normal as well as compromised
pregnancies. The resultant in-depth biomolecular profiles and spatial tissue maps obtained for normal term and
preterm pregnancies with the innovative Raman approaches will provide vital information about the mechanism
of premature cervical remodeling and for monitoring longitudinal changes in the structural and biochemical
properties of other tissues with RS.

Public health relevance
NARRATIVE Elucidating the biochemical and conformational changes that initiate cervical ripening will provide a critical step for early detection and treatment of preterm birth, which is the leading cause of infant morbidity and mortality. Raman spectroscopy is a non-invasive, label-free, and highly specific approach for probing tissue biochemistry, which can be implemented in vivo using a fiber optic probe. This proposal will develop multimodal in vivo Raman spectroscopy along with complementary ex vivo imaging techniques to gain in-depth, quantitative information regarding changes in extracellular matrix organization, lipid and water content, and vascularity in order to understand how these components are altered in mouse models of premature cervical remodeling and preterm birth.